RNA Processing Misregulation in KIF5A ALS

PROJECT SUMMARY
Amyotrophic Lateral Sclerosis (ALS) is a fatal neurodegenerative disease that was previously considered mainly
a disorder of protein mislocalization. However, recent findings have unveiled a significant association of ALS
with RNA misregulation. Among the 53 genes linked to ALS, the gene KIF5A has recently garnered attention.
KIF5A, a kinesin motor protein known for its role in organelle transport, has been implicated in ALS through
mutations that purportedly lead to a gain-of-function, resulting in a hyperactive state of the protein. My research
has utilized machine learning predictions alongside experimental approaches to demonstrate that KIF5A
functions as an RNA-binding protein. Moreover, I found ALS-related mutations in KIF5A modify its RNA-binding
profile, uncovering a novel aspect of KIF5A's involvement in ALS. My preliminary findings indicate that KIF5A
with ALS mutations exhibits a preference for binding to mRNA of heat shock proteins and several other genes
associated with ALS. I propose that mutations in KIF5A contribute to motor neuron degeneration by disrupting
RNA processing. The proposed research encompasses three objectives: (1) to investigate the impact of KIF5A
ALS mutations on the proteotoxic pathway, (2) to explore the interactions between KIF5A and ALS-associated
genes and RNA targets, and (3) to evaluate the effects of KIF5A mutations on transcription, RNA localization,
and RNA-binding protein (RBP)-RNA interactions using spinal organoid models. Success in this project will lay
the groundwork for innovative methods and insights into the misregulation of RNA processing in ALS. My
expertise in quantitative, single-molecule imaging, combined with the Yeo lab's profound knowledge in RNA
processing, stem cell models and neurodegeneration, positions me uniquely to lead the proposed research.
These objectives will establish a foundation for my career as an independent researcher, focusing on the
mechanisms of RNA transport in neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE There’s currently no cure for Amyotrophic Lateral Sclerosis (ALS), with a prognosis of death within 3-5 years post-diagnosis. This research proposal aims to understand how recently discovered mutations in KIF5A gene lead to RNA mislocalization and disfunction using stem cell models of ALS. If successful, this work will clarify the molecular mechanisms and identify potential therapeutic intervention strategies for KIF5A ALS.